Clinical, Immunological and Genetic Analyses of ALPS

Research accomplishments of this project during the past year include: [unreadable] [unreadable] 1.) Clarified the designation of a seventh subtype of ALPS, ALPS Type IV, based on the identification of the new molecular defect described above. Provided is the classification scheme that we have devised for ALPS patients based on the particular molecular defect present: [unreadable] Type Ia: mutations in the TNFRSF6 (tumor necrosis factor receptor superfamily 6) gene, encodes the protein CD95 (Fas, Apo-1).[unreadable] Type Ia: somatic mutant: TNFRSF6 gene defect in the double negative T (DNT) cell population. [unreadable] Type Ib: mutations in TNFRSF6 gene, encodes the protein CD95 ligand (Fas ligand).[unreadable] Type IIa: mutations in CASP10 gene, encodes caspase-10.[unreadable] Type IIb: mutations in the CASP8 gene, encodes caspase 8.[unreadable] Type III: associated mutation unidentified to date.[unreadable] Type IV: mutations in NRAS. [unreadable] [unreadable] 2.) The extended evaluation, management and duration of follow-up using Mycophenolate mofetil (MMF) for the treatment and prevention of ALPS-related complications. Our experience with MMF as an effective, well-tolerated steroid-sparing long-term maintenance immunomodulatory therapy in the subset of children with refractory ALPS-associated cytopenias associated with splenomegaly and/or autoimmunity is positive. Reviewed our experience with MMF, Rituximab in the context of ALPS patients with refractory cytopenias over the last 10 years.[unreadable] [unreadable] 3.) Extended in vitro and in vivo studies of potential therapeutic drugs in the MRL/lpr (ALPS) mice, testing their capacity to reduce lymphadenopathy and splenomegaly, and key biological markers in ALPS. Valproic acid, a histone deacetylase inhibitor, reduced splenomegaly, lymphadenopathy and CD3+CD4-CD8-alpha beta TCR+T cells (DNTs) in the spleen and blood of MRL/lpr mice. In vitro, using both normal and ALPS Type Ia peripheral blood mononuclear cells (PBMCs), valproic acid was able to induce cell death in a dose-dependent manner. Cell death appeared to be both caspase-dependent and -independent based on partial inhibition with the pan-caspase inhibitor, Z-VAD-FMK.[unreadable] [unreadable] 4.) Extended the use of PET scans as an imaging modality in patients with ALPS associated lymphadenopathy as a tool to monitor patients with suspected ALPS associated lymphoma.